Genomics of OCD in Latin American Communities

PROJECT SUMMARY
In this study, I seek to understand how common and rare genetic variation influences the risk of developing
obsessive-compulsive disorder (OCD). OCD is a disabling psychiatric condition with unclear pathophysiology,
which has hindered the development of effective treatments and interventions. Although there is strong evidence
of genetic contribution to OCD risk, decades of research have not yet produced reproducible, statistically
significant findings that identify high-confidence risk genes. In contrast, other neurodevelopmental psychiatric
disorders (NDDs)—including schizophrenia, attention-deficit/hyperactivity disorder (ADHD), and autism—have
seen major advances through genome-wide association studies (GWAS) and whole-exome sequencing (WES)
in large samples. These efforts have identified risk loci and genes, paving the way for novel therapeutic targets.
Similar progress in OCD is expected as sample sizes increase and multi-omic approaches are applied.
However, most existing OCD studies have focused on individuals of European ancestry (EA), limiting
generalizability and our understanding of genetic risk in diverse populations. Expanding studies to include
globally diverse populations is essential for comprehensive risk gene discovery. Such inclusion facilitates finemapping through differences in allele frequency, enables the investigation of recent rare and ancient functional
alleles that may be absent in EA cohorts, and allows examination of complex inheritance patterns such as
compound heterozygosity and digenic/oligogenic models. These approaches are vital to advancing our
understanding of psychiatric disease biology.
To address this gap—and with the ultimate goal of identifying the role of common and rare deleterious variants
in OCD—I will analyze rare and common genetic variation in OCD samples, building on prior work during the
K99 phase, during which I collected 380 Latin American ancestry (LA) OCD trios. These will be combined with
150 trios from the Rutgers Center for Genomics of Psychiatric Health, totaling 530 trios for this project. The main
objectives are to: a) Identify OCD risk genes impacted by rare deleterious variants via meta-analyses with OCD
case-control data from the LATINO study; b) Identify OCD risk genes impacted by common variation using
ancestry-informed GWAS; and c) Contribute all data to the Psychiatric Genomics Consortium (PGC) OCD
Working Group and LATINO consortium to enhance statistical power and fine-mapping of risk loci.
While previous OCD studies have largely relied on broad case-control comparisons, this proposal will integrate
genomic data from trios with clinical and environmental variables—such as trauma exposure, treatment history,
and geolocation—to uncover gene-environment interactions and modifiers of genetic risk. These analyses will
move beyond diagnostic categories, allowing for phenotype refinement and the identification of biologically
meaningful dimensions of heterogeneity. Finally, we will begin exploratory work to evaluate whether OCD risk
genes converge with cortical structural alterations and transcriptomic profiles, contributing to a deeper
neurobiological understanding of OCD

Public health relevance
This research is relevant because it may advance gene discovery in OCD, illuminate the molecular pathways underlying structural brain alterations, and ultimately inform more precise and effective treatments